Center for Research and Education on Aging and Technology Enhancement - CREATE

Project Summary/Abstract
About two million homebound (HB) older adults live in the community in the US, which is almost 1.5 times the
total of older adults in nursing homes. HB older adults are a diverse population, with complex medical and
social needs, and experience high levels of chronic conditions. Minoritized populations are disproportionally
affected by HB status and multiple chronic conditions (MCC). In addition to the lack of financial resources,
transportation, and physical limitations, multiple stressors associated with managing MCC pose significant
barriers to maintaining social contacts and activities. However, the wide range of interventions involving older
adults who are HB and living with MCC have not addressed social engagement in this population. Social
engagement is a critical indicator of well-being and health, and provides individuals living with MCC a sense of
purpose, control, and self-efficacy in coping with MCC. Still, minority groups are highly underrepresented in
most interventions, and knowledge about HB older minority with MCC’s challenges with social engagement
and the implementation and evaluation of technology-based social engagement interventions in this target
population are not known. The proposed 2-year project will address these significant gaps.
Using an asset-based approach, our aims are: 1) Ascertain social engagement needs and challenges, and
preferences regarding technology-delivered interventions among HB minority older adults with MCC, and elicit
case managers’ perspectives on social engagement challenges of HB aging adults; 2) Conduct usability testing
with HB minority older adults with MCC of a Virtual Reality intervention designed to facilitate social
engagement. The Virtual Reality intervention will be adapted based on the findings in Aim1; 3) Conduct an
uncontrolled pilot study to evaluate, using standard metrics, the acceptability and feasibility, and further data on
usability of the social Virtual Reality intervention in a sample of older minority HB adults with MCC in home
settings.
We will use a qualitative approach in Aim 1 to better understand the perceived benefits and drawbacks of
social engagement in HB minority older adults, a mixed methods approach to test the usability of the adapted
intervention in Aim 2, and a pre-post design to gauge the feasibility and acceptability of this intervention in Aim
3. Our interdisciplinary team is uniquely qualified and has an optimal range of backgrounds, expertise, and
experience to conduct this study. Findings from this project will generate evidence on technology-delivered
social interventions as means to facilitate social engagement in the target population, to help mitigate
loneliness and social isolation, and inform future design guidelines.

Public health relevance
Project Narrative Homebound (HB) older adults have complex medical and social needs, experience multiple chronic conditions (MCC) and are at high risk for loneliness and social isolation due to multiple stressors associated with managing MCC, posing significant barriers to maintaining social connections and activities. This project proposes to determine, using an asset-based approach, the social engagement’s needs, preferences, and challenges of HB minority older adults with MCC and assess the usability, acceptability, and feasibility of a Virtual Reality intervention in meeting these needs. This project will generate new knowledge in this highly under-studied area and has the potential to be sustainable through providing a focus on technology-delivered interactions for social engagement activities, which can contribute to reducing health and digital disparities and help in mitigating social isolation and loneliness.